Molecular Pharmacology of the Synaptic and Extrasynaptic GABA(A) Receptors

The family of γ-aminobutyric acid type A receptors (GABA(A)Rs) are the major inhibitory neuro–
receptors in the human brain. Some two dozen isoforms, each made up of five subunits selected from the
19 established subunits, mediate many different physiological pathways associated with consciousness,
sedation, anxiety, epilepsy, depression and postpartum depression. Mutations in the GABA(A)R subunits
are associated with diseases such as epilepsy and schizophrenia. They are also the target of many drugs
that for example reversibly suspend conciousness or seek to control epilepsy or anxiety without inducing
sedation. Our overall long-term goal is to establish the relationship between the structure of synaptic and
extrasynaptic GABA(A)R and how they function. The basic strategy, established in two recent papers, is to
use single particle cryo-EM to determine structures of full-length, glycosylated human GABA(A)Rs, purified
and reconstituted in a state that preserves conformation changes and to use the same receptors to study
structure and function in parallel. This is possible because of the development of inducible, high yielding
stable cell lines. During activation and deactivation, GABA(A)Rs undergo conformation changes that open
and close allosteric sites some of which are used by endogenous ligands (e.g. neurosteroids) and other by
drugs (e.g. general anesthetics, benzodiazepines). These allosteric ligands, discovered serendipitously,
provide clues to the existence of such sites. We aim to provide a basic understanding of how the
structure of these allosteric pockets depends on a receptor’s conformation. This will provide the basic
mechanistic knowledge that will enable others to develop ways to control GABA(A)R function. Our working
hypothesis is that allosteric sites located between subunits in the TMD can accommodate positive and
negative allosteric modulators (PAMs and NAMs respectively) as well as null allosteric ligands (NALs), just
as benzodiazepines can in the α+/γ– interface in the ECD. Our first specific aim concerns extrasynaptic
receptors, which do not contain a benzodiazepine site. Here the basic information on stoichiometry and
subunit arrangement is lacking, and this problem must be addressed first. Two ligands, DS2 and ketamine,
both selective for δ-subunit–containing extrasynaptic receptors, provide clues to the existence of unique
allosteric sites, perhaps in contact with the δ-subunit, that open up during activation. The second specific
aim tests the hypothesis that agents binding in the TMD of synaptic receptors can act as PAMs, NAMs and
NALs. PAMs are well established, and this aim focuses on NAMs and NALs. Based on existing structures in
several conformations, we will design and synthesize NAMs and NALs with the goal of obtaining ligands
suitable for structural determination that will improve the mechanistic understanding of GABA(A)R function.
The significance is that this may lead to the development of anesthetic antagonists (NALs) and sedative
(partial NAMs), as well as a deeper understanding of the mechanisms of GABA(A)R function.

Public health relevance
This project is relevant to public health because it represents a new approach to understand the major inhibitory neuroreceptors in the human brain by determining their structures in a functional state and elucidating the mechanisms of drugs that modulate their behavior. This new understanding will enable the design of new pharmacological agents against CNS disorders such as anxiety, epilepsy and depression. The proposed research is relevant to the mission of the Pharmacological and Physiological Sciences Branch of NIGMS.